FLUORESCENCE ASSISTED INFRARED MICROSPECTROSCOPY TO STUDY OF OSTEOPOROSIS

Infrared spectroscopy provides an excellent means for examining the secondary structure of proteins. The deconvolution of the Amide I band (1600 - 1700 cm-1), which is primarily a C=O stretching mode of the peptide linkage that forms the protein backbone, provides details of the percent of the protein structure that is α-helical, β-sheet, β-turn, or extended coil. Using sensitive infrared spectroscopic techniques and powerful deconvolution methods such as Fourier self deconvolution and second derivative analysis, infrared spectroscopy can study the detailed changes in secondary structure with unfolding. It is beneficial to study protein folding in a time-resolved fashion, however the time limit of a conventional stopped flow mixers is on the Horder of several milliseconds and requires relatively large solution Hvolumes. However, the use of bright light sources, such as lasers H(for Raman or fluorescence spectra) and synchrotron infrared light H(for FTIR spectra), significantly reduce the large areas (and hence Hvolumes) that are necessary. Volume elements on the order of 10 μm x H10 μm x 10 μm (~1 pl) are sufficient to obtain high quality spectra.